Role for Circular RNAs in Compulsive Cocaine Intake

PROJECT SUMMARY/ABSTRACT– PROJECT 2
Project 2's objective is to understand the role for circular RNAs (circRNAs) in the mechanisms by which
cocaine remodels the dorsal striatum (DS) and nucleus accumbens (NAc) to precipitate compulsive cocaine-
seeking behaviors. circRNAs are highly conserved single-stranded ‘back-spliced’ RNAs in which the 5′ and 3′
ends of the transcript are covalently joined. Emerging evidence suggests that circRNAs are a major class of
regulatory noncoding RNAs that are enriched in brain and that play key roles in basic aspects of neuronal
function, but their involvement in the molecular, cellular, and behavioral actions of cocaine (and other drugs of
abuse) has yet not been investigated. We will characterize patterns of circRNA expression in DS and NAc of
mice that show compulsive-like cocaine consumption using paired-end ribominus RNA-sequencing. We will
also assess circRNA expression in postmortem striatal tissues from humans with cocaine use disorders. We
already have robust evidence for prominent cocaine regulation of several circRNAs in these brain regions.
Those cocaine-responsive circRNAs that show similar abnormal expression in mice and humans will be
prioritized for further investigation. We will determine whether prioritized cocaine-responsive circRNAs are
regulated specifically in different types of DS and NAc neurons. We will then investigate the role played by
these prioritized cocaine-responsive circRNAs in regulating the molecular and cellular responses to cocaine
within these cell types of DS and NAc. This will be accomplished by use of in vivo CRISPR technology or RNAi
to knockdown prioritized circRNAs in a cell type-specific manner and assess the influence of these circrRNAs
in controlling baseline and cocaine-induced alterations in the intrinsic excitability of the neurons as well as their
transcriptional responses to cocaine. Finally, we will investigate the ways in which cocaine-responsive
circRNAs control compulsive-like cocaine self-administration behavior including relapse in mice. These highly
innovative studies promise to yield fundamentally new insights into the molecular and cellular mechanisms of
cocaine addiction, with parallel future studies planned for opiate drugs of abuse.

Public health relevance
PROJECT NARRATIVE – PROJECT 2 Addiction remains one of the world’s greatest public health problems, yet its pathophysiology remains incompletely understood and available treatments for addictions to various drugs of abuse are inadequately effective for most people. The Project’s focus on circular RNAs is a critical part of this Program Project Grant’s efforts to contribute to a better understanding of the neurobiological basis of addiction, which we believe will facilitate the eventual development of definitive treatments and cures for substance use disorders.